Immunologic correlates of functional cure of HBV with immune checkpoint blockade

Chronic viral infections remain major threats to global health, with pathogens such as hepatitis B virus (HBV)
responsible for millions of deaths annually. Despite availability of an HBV vaccine and suppressive antiviral
treatment, the worldwide burden of chronic HBV infection has remained unchanged. Short-term therapies
capable of producing at least functional cure for chronic HBV are therefore a high priority. Exhaustion of the
immune system, most obvious in HBV-specific CD4 and CD8 T cells, is a key factor in HBV persistence and
disease. The PD-1:PD-L1/2 inhibitory receptor pathway regulates many key aspects of cellular immunity,
including T cell exhaustion in chronic viral infection and cancer. Blockade of this pathway has produced dramatic
effects in the treatment of advanced cancer and unleashed an immunotherapeutic revolution. However, little is
known about the effect of PD-1 blockade in chronic infections in humans, the mechanisms by which responses
are invigorated, and how a reinvigorated HBV immune response impacts the intrahepatic HBV replication
landscape. We propose to comprehensively investigate how blockade of PD-1 in humans affects the layers of
molecular regulation of the antiviral immune response, and how this impacts viral replication in situ. The overall
hypothesis of this project is that blocking PD-1 in humans will alter the magnitude, quality, regulation and
composition of pre-existing antiviral CD4 and CD8 T cell responses, leading to more effective viral control, will
modulate other aspects of cellular innate immunity, notably macrophages, and will lead to diminished viral
replication in hepatocytes. We will test this hypothesis through the following aims. Specifically, in Aim 1 we will
test whether and how PD-1 therapy invigorates exhausted virus-specific CD4 and CD8 T cell responses
in the blood and liver. We will utilize liver fine needle aspirates and PBMC samples for a comprehensive and
in-depth analysis of changes in the phenotype, function, clonal composition, and transcriptional state of HBV-
specific CD4 and CD8 T cells. In Aim 2 we will test whether PD-1 therapy diminishes active HBV
transcription in hepatocytes. Using an integrated platform of single-cell laser capture microdissection and
droplet digital PCR on frozen liver tissues, we will quantify cccDNA and pre-genomic HBV RNA in hundreds of
individual hepatocytes from participants before and at the completion of PD-1 blockade. Finally, in Aim 3 we
will define the recovery of macrophages through PD-1 blockade in persons with chronic HBV infection.
Here using FNA and PBMCs from patients with chronic HBV, we will assess whether αPD-1 treatment shifts the
composition of macrophage populations toward an antiviral phenotype and test whether the functional
responsiveness of monocyte/macrophages correlates with αPD-1 treatment outcome. Collectively, we expect
these data to dramatically enhance our understanding of the mechanism of αPD-1 mediated immune recovery
that can be utilized not only for the design of pathogen-specific immunotherapy, but also to enable further
improvements in the efficacy of immunotherapy in general.

Public health relevance
Blockade of the T cell inhibitory receptor PD-1 has revolutionized cancer therapy and is now explored for treatment of chronic viral infection, another condition marked by exhausted immunity. In this project we will evaluate whether and how PD-1 blockade enhances immunity to hepatitis B virus (HBV) in an HBV PD-1 blockade trial. The expected results will dramatically increase our understanding of the molecular response to PD-1 blockade and thus will enable further refinement of these groundbreaking new therapies.